41st National Neurotrauma Society (NNS) Annual Symposium 2024 - Future Classics of Neurotrauma

Abstract
Neurotrauma, such as traumatic brain injury (TBI) and spinal cord injury (SCI), impacts over 60 million people
per year globally with an estimated fiscal burden of $400 B/year. The National Neurotrauma Society (NNS) is
committed to the promotion of neurotrauma research by enhancing communication, providing a forum for
scientific exchange, and increasing national and international support for neurotrauma research and clinical
advances. Every year, the society holds a symposium to meet this goal and provide a forum for researchers,
clinicians, and trainees from around the world to meet and discuss the latest breakthroughs to improve the
lives of individuals living with TBI and SCI related disability. The 41st Annual Neurotrauma Symposium,
jointly sponsored by the NNS and the American Association of Neurological Surgeons/Congress of
Neurological Surgeons (AANS/CNS) Joint Section on Neurotrauma and Critical Care will be held in San
Francisco, CA, June 9 - June 14, 2024. This meeting will focus on showcasing the latest technological
innovations in the neurotrauma field while celebrating the foundational biomedical research that continues to
influence emerging knowledge and tools to improve neurotrauma research and clinical care. Broad objectives of
the Symposium include: 1) updating attendees on current and timely topics in basic and clinical neurotrauma,
2) facilitating exchange of information among participants, 3) building new scientific collaborations, with a
foundation in rigor, reproducibility, transparency, and translation, and 4) fostering active engagement of
trainees and young investigators through our travel awards, poster competition, data blitz oral presentations,
workshops and activities developed and supported by the Training, Education and Mentoring (TEAM)
Committee. NIH funding for previous NNS Symposia has provided invaluable support for scientific sessions
and for enhancing our ability to reach graduate students, postdoctoral researchers, residents, and young
investigators. NIH support helps the NNS to provide travel awards to continue to promote trainee attendance,
including underrepresented minorities (URM), women, and persons with disabilities. This application seeks
funding to support 30 pre-and-postdoctoral trainees to present their ongoing work, attend scientific sessions,
and to network with peers and faculty. Of the 30 trainees, at least 10 will meet the NIH definition of persons
underrepresented in the biomedical workforce, including URMs, women, and individuals with disabilities as the
society strives to continue to promote and retain diversity. In addition, we request support for programming for
trainee and young investigator development sessions, sponsored by the TEAM Committee. Finally, we request
support to continue our unique Local Scholars Program (LSP), successfully initiated in 2022, which provides
support for undergraduate students who come from under- served backgrounds and who attend local
universities to attend the NNS Symposium, and receive specific training to promote interest in careers in
neurotrauma and neuroscience research.

Public health relevance
Project Narrative Traumatic brain injury (TBI) and spinal cord injury (SCI) are a major public health burden that often lead to lifelong impairment and disability. The National Neurotrauma Society (NNS), largely through its annual Symposium, is a critical translational research resource for sharing the latest advances in the neurotrauma field, with the ultimate goal of improving the treatments available to patients. Ongoing support for this annual meeting ensures a major national investment in advancing and innovating neurotrauma research and in the career development of trainees, with a focus on opportunities for increasing and retaining diversity in trainees and faculty in the neurotrauma field.